Interventional Agents Safety and Pharmacokinetic Services

The Interventional Agents Safety and Pharmacokinetic Services (IASPS) program provides for preclinical/nonclinical services and activities required for the development of interventional products for infectious diseases including IND, NDA, or BLA for advanced products.